Administration

Administration The activities of the JCCC Administration provide support in the following areas to aid the Center's mission and goals: • Planning and evaluation of research programs, shared resources. • Fiscal control of Cancer Center accounts, including fund/grant management of both public and private funds. • Communication support services, including programmatic exchanges among JCCC leadership and members, public affairs and education. • Organization and logistics support for program area retreats, meetings, outside speakers and symposia. • Coordination and development of Information Technology resources to support the planning and evaluation activities of the Center. • Management of Information Technology providing data access for internal use, as well as providing a worldwide resource to scientists, physicians and patients. • Management of the Cancer Center's facilities, space and equipment. • Human Resource management. Partial funding is requested for positions that are in direct support of the UCLA-JCCC CCSG.